Rapid, safe suppression of IgE-mediated disease with monovalent anti-ceRIa mAb

This proposal tests the hypothesis that sustained, limited in vivo crosslinking of the high affinity IgE
receptor, FcεRI, on mast cells (MCs) and basophils (BAs) rapidly desensitizes these cells and safely and
effectively prevents IgE-mediated diseases, such as food allergy and anaphylaxis. Rapid desensitization (RD)
is traditionally a procedure in which MCs and BAs from people who have IgE-mediated allergy to a specific
allergen are made temporarily unresponsive to that allergen by exposure to increasing allergen concentrations
over several hours. We modified RD by inoculating mice with increasing concentrations of an anti FcεRI α
chain mAb. These studies showed that: (1) RD with anti-FcεRIα mAb is effective, safer and longer lasting than
RD with allergen; (2) RD with anti-FcεRIα mAb is antigen-nonspecific; (3) MC unresponsiveness can be safely
sustained by maintaining serum levels of this mAb; (4) this process works with anti-human (hu) FcεRIα mAbs
in mice that express hu, rather than mouse FcεRIα (huFcεRIα mice); and (5) RD depends both on induction of
MC anergy and removal of MC FcεRI and IgE. Recently, we have found that IgE-mediated anaphylaxis can be
fully suppressed in huFcεRIα mice, without adverse effect, by repeatedly injecting <1 µg of IE7, a mouse mAb
that binds to huFcεRIα regardless of FcεRI association with IgE. These mice can also be safely and dose-
dependently desensitized by a single injection of a monovalent (mv) form of IE7 that has human IgG1-derived
constant regions (mv huIgG1 IE7). mv huIgG1 IE7 also depletes blood BAs, and removes ~90% of MC IgE, but
little FcεRIα. The loss of MC IgE and particularly, its disproportionate loss compared to FcεRI, was
unexpected, because IE7 does not cause MCs to lose IgE in vitro and this mv Ab should only crosslink FcεRI if
the Ab becomes multivalent by aggregating or by binding to cellular Fcγ or complement receptors.
This proposal builds on these observations. Aim 1 uses flow cytometry, structural studies, anti-FcγR mAb,
and hu IgG isotype switch variants of mv IE7 to determine whether mv huIgG1 IE7 crosslinks FcεRI in vivo
and, if so, through what mechanism(s). Aim 1 also evaluates whether mv huIgG1 IE7 aggregation or
internalization of IgE-loaded FcεRI is required for the disproportionate in vivo loss of MC IgE. Aim 2 applies
Aim 1 results to use mv IE7 to safely desensitize actively sensitized, hyperallergic huFcεRIα mice that express
a mutant IL-4 receptor as well as passively sensitized hu cord blood-reconstituted, hu cytokine-secreting,
immunodeficient mice that develop large numbers of activated hu MCs and BAs; both models have been
difficult to desensitize with increasing doses of divalent IE7. Aim 3 applies aim 2 results to desensitize rhesus
monkeys, which express FcεRIα that reacts with IE7. Together, these aims should optimize the use of mv anti-
FcεRIα mAb for RD and suggest whether and how it could be used to suppress hu IgE-mediated disease.

Public health relevance
Mast cell/FcεRI/IgE-mediated allergy is common, causes considerable morbidity, and can be life-threatening. Allergen rapid desensitization only suppresses allergy to targeted allergens, has adverse effects and typically requires daily allergen exposure. We have developed the reagents and protocols for rapid desensitization with a monovalent anti-FcεRIα antibody and have shown that this procedure is effective, safe, simple, and quick in mouse models. Determining how it works and testing its safety and efficacy in highly allergic humanized mice and rhesus monkeys will allow optimization of this approach and set the stage for clinical trials.